HEU outcomes: population-evaluation and screening strategies (HOPE)

ABSTRACT
There is a substantial and growing population of children/adolescents who are HIV exposed uninfected (HEU)
in sub-Saharan Africa (SSA). There is emerging evidence that fetal exposure to maternal infections and
medications may result in adverse adult/adolescent mental health outcomes; it is plausible that fetal exposure to
HIV or antiretrovirals (ART) could similarly influence long-term outcomes. Despite evidence for poor growth
and neurodevelopmental deficits, programs to systematically monitor neurodevelopmental and mental
health outcomes among HEU at a population level are lacking. Understanding whether there are increased
adverse neurodevelopmental and mental health outcomes in HEU due to fetal HIV/ART exposure has been
challenged by difficulties in defining appropriate comparator cohorts, changing PMTCT treatment guidelines, and
lack of validated, scale-able assessment tools.
Our team has a unique track record for moving novel approaches for screening and testing from pilot to
implementation, conducting large scale evaluations, and conducting neurodevelopmental and mental health
assessments in HIV-affected children and adolescents. We propose parallel longitudinal and population
based HEU/HUU cohorts, in urban and rural settings, spanning infants/children/adolescents age 6 weeks
to 18 years to determine differences in neurodevelopmental and mental health outcomes. The R61 phase
will accrue a longitudinal homogenous cohort of 2000 HEU/HUU infants exposed to Option B+ PMTCT treatment
regimens, with extended follow-up in the R33 phase for a total of for 4 years, and assessed for
neurodevelopmental, mental health, hearing, growth outcomes and telomere length. An approach to survey older
HEU/HUU (age 3-18) for neurodevelopmental and mental health outcomes and collect maternal medical, ART
regimen and timing, and viral load data from medical records will be piloted in the R61 phase and expanded to
100 HIV clinics in the R33 phase. Selected neurodevelopmental/mental health screening and diagnostic tools to
be used are based on open source availability, diagnostic or screening performance, cultural appropriateness,
accessibility, and clinical relevance. In the national R33 survey, cost analysis will complement clinical data; and
together, will be disseminated to stakeholders at a workshop to develop a framework for an integrated HEU
screening program in public health settings.
This proposal leverages extensive team experience in prior longitudinal MTCT cohorts, in national child and
adolescent surveys, HEU recruitment, neurodevelopmental and mental health assessment, and medical record
extraction and analysis at scale, to comprehensively understand burden, mechanism and outcomes in HEU.
Engaging stakeholders has the potential to enhance HEU management programmatically based on findings.

Public health relevance
NARRATIVE Globally there is an increasing number of HIV-exposed but uninfected children and adolescents (HEU). We propose to evaluate HEU in Kenya, spanning from infancy to adolescence using different epidemiologic approaches to determine whether HEU have increased risk of adverse neurodevelopmental or mental health outcomes. We plan to screen a large population of HEU nationally and work collaboratively with stakeholders to review this data to inform approaches to screen, identify, and refer HEU with adverse outcomes, that could be used programmatically.